Tissue Organoids as Models of Host Physiology and Pathophysiology of Disease

ABSTRACT Support is requested for a Keystone Symposia conference entitled Tissue Organoids as Models of Host Physiology and Pathophysiology of Disease, organized by Drs. Thaddeus S. Stappenbeck and Linda G. Griffith. The conference will be held in Vancouver, British Columbia Canada from January 19-23, 2020. Tissue organoids are becoming an increasingly sophisticated experimental system that is of importance in investigative work on nearly every organ system. There has been a recent explosion of techniques and platforms that enable dissection of fundamental questions, modeling cellular alterations in disease states and screening of compounds and molecules to discover new pathways. Fundamental work into organoid properties has developed the potential of organoids to become new methods for diagnosis, therapeutic selection and even to serve as regenerative medicine therapeutics themselves. This conference will bring together experts in organoids from various tissues and will create valuable cross-fertilization of ideas and approaches that will benefit many fields. A major gap is that this technology is being siloed in areas of specific tissues and molecular pathways. A general conference that cuts across all organs and major utilities will be of high value and will encourage groups to share ideas across organ systems. The conference program will also include engineering approaches that will highlight novel developments in organoid technology. As a result of this conference, it is anticipated that participants will have a much better understanding of the capabilities of organoid systems and see new avenues for exploration. This conference is designed to emphasize synthesis over reductionism. An additional aim of this conference is to help investigators make the connection to develop new diagnostic and therapeutic tools using organoids.

Public health relevance
PROJECT NARRATIVE Due to the growing understanding of human biology, along with increased availability of innovative technologies, there is now an unprecedented opportunity to translate scientific discoveries more efficiently into new, more effective and safer health interventions for many different diseases that affect the human population. Tissue organoids are innovative, alternative approaches that would enable early indications and potentially more reliable readouts of toxicity and efficacy over many medications that are ultimately found to have unfavorable clinical trial results. This conference will touch on ongoing efforts and various applications of tissue-on-chips technology to studies in areas such as precision medicine, environmental exposures, reproduction and development, and cancer.